Repair of Genome Destabilizing DNA Structures

PROJECT SUMMARY
Cancer incidence increases with age in a tissue-specific fashion. Genetic instability and epigenetic alterations
(e.g., cytosine methylation) are hallmarks of both cancer etiology and aging, thus linking aging to cancer.
Importantly, alternative DNA structure-forming sequences (i.e., non-B DNA) have been identified as
endogenous mutation hotspots associated with cancer etiology in an age-related and tissue-specific fashion.
Further, methylation can impact non-B DNA formation, its mutagenic potential, and DNA repair mechanisms;
and the mutagenic processing of non-B DNA requires DNA repair proteins. However, the mechanisms involved
in the age-related and tissue-specific generation of these mutation “hotspots” remain largely unknown. With the
aging population increasing, there is a critical need to fill this fundamental gap in knowledge. Our long-term
goal is to elucidate the mechanisms of age-associated, tissue-specific DNA structure-induced genetic
instability to guide future studies to develop new strategies to prevent and/or treat cancer. Thus, the overall
objective of this application is to determine the mechanisms involved in differential DNA structure-induced
genetic instability with age and tissue type to inform on cancer etiology. We will test the novel hypothesis that
the formation of non-B DNA and their mutagenic processing differ with age in a tissue-specific fashion due to
alterations in DNA repair processing and cytosine methylation. The rationale is that determining the
mechanisms associated with age-related, tissue-specific DNA structure-induced genetic instability will offer a
novel scientific framework whereby new strategies to prevent and/or treat age-associated diseases, such as
cancer, can be developed. The hypothesis will be tested in the following aims: 1) Measure the amount of non-B
DNA formed and its mutagenic potential with age in mouse tissues; 2) determine age- and tissue-associated
alterations in cytosine methylation that alter non-B DNA structure formation and mutagenesis; and 3) identify
the DNA repair-associated mechanisms of mutagenic processing of endogenous mutation hotspots with age in
mice. Novel mutation-reporter mice containing human non-B DNA sequences from cancer-associated mutation
hotspots will be used to determine the effects of age and tissue type on the mutagenic processing of non-B
DNA. This is innovative because it will test the novel hypothesis that DNA structure-induced genetic instability
is altered with age and tissue type in mammals, dependent on age-related modulations in epigenetics and
DNA repair. The expected contribution is the elucidation of the impact of age and tissue type on DNA structure-
induced genetic instability, which is significant because the results will inform on the etiology of various cancer
types with age. This is expected to have a significant positive impact because the results will help achieve our
long-term goal to understand the mechanisms of age-associated, DNA structure-induced genetic instability in
various tissues to guide future studies to develop new strategies to prevent and/or treat cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The proposed research is relevant to public health because it is known that cancer risk increases with age, and that genetic instability and epigenetic alterations (e.g., cytosine methylation) are hallmarks of both aging and cancer; yet the underlying mechanisms involved and to what extent they are associated are not clear. We have found that alternative DNA structures serve as endogenous mutation hotspots in human cancer genomes, and that DNA structure-indcued genetic instability is altered with age in a tissue-specific fashion and by cytosine methylation; thus, we will explore the underlying mechanisms involved to inform on the development of various types of cancer. Results from the proposed study are expected to have a significant positive impact by delineating the relationship between tissue-specific DNA structure-induced genetic instability and epigenetic modification- related non-B DNA formation and instability as a function of age, which will guide the long-term goal of developing new strategies to prevent and/or treat age-associated diseases, such as cancer.